Unveil the functional role of RNA spatial localization in neuronal function and neurodegeneration by developing novel CRISPR-TO tools

PROJECT SUMMARY
RNA molecules are essential for neuronal function, playing a key role in coordinating gene expression across
different cellular compartments. Various RNAs, including messenger RNA (mRNA), microRNA (miRNA), and
long non-coding RNA (lncRNA), respond rapidly to environmental cues and synaptic activity, supporting critical
processes such as axonal growth, synaptic plasticity, and long-term memory formation. The spatial organization
of RNAs within neurons enables localized protein synthesis at synapses, spanning distances from millimeters to
meters, and is vital for nerve repair. Moreover, dysregulation of RNA-binding proteins, such as TDP-43, has
been linked to various neurodegenerative diseases like amyotrophic lateral sclerosis (ALS), frontotemporal
dementia (FTD), and Alzheimer’s Disease. Since these proteins are involved in alternative splicing,
polyadenylation, transcription activation, translation, and RNA spatial localization4, it suggests a strong
pathological link between RNA regulation and disease progression. Despite progress made in understanding
other functional aspects of RNA-binding protein dysfunction (e.g., cryptic splicing), however, the functional role
of spatial RNA localization in disease development remains largely underexplored, due to the lack of efficient
tools for manipulating and perturbing endogenous RNA spatial localization to infer its causal physiological or
pathological function.
To investigate how RNA spatial mechanisms govern neuronal functions, my colleagues and I have recently
developed a novel technology termed CRISPR-mediated transcriptome organization (CRISPR-TO) to perturb
endogenous RNA spatial localization in neurons. I propose to use this novel CRISPR-TO tool to enable
programmable control of endogenous RNA localization both in vitro and in vivo to study and create future
treatment for neurodegenerative diseases. CRISPR-TO will first be applied in vitro using human induced
pluripotent stem cell (hiPSC)-derived neurons from healthy individuals and neurodegenerative disease patients
to identify RNA localization targets (Aim 1-2). These findings will then be translated in vivo via AAV delivery of
CRISPR-TO to test how RNA spatial regulation influences disease progression and functional outcomes in
preclinical models (Aim 3). If successful, this study can transform how we investigate RNA mislocalization in
neurodegenerative diseases, uncovering novel mechanisms that contribute to disease progression and neuron
regeneration. By enabling scalable, programmable control of endogenous RNA localization, we could pave the
way for innovative spatial RNA therapeutic strategies, with implications far beyond ALS, extending to other
neurological and systemic diseases where RNA localization plays a critical role.

Public health relevance
PROJECT NARRATIVE RNA molecules regulate neuronal function, but dysregulated RNA localization in neurodegenerative diseases lacks targeted intervention tools. We developed CRISPR-mediated transcriptome organization (CRISPR-TO) to program RNA spatial dynamics, leveraging patient iPSC-derived neurons and AAV delivery to model disease mechanisms. This work will define RNA localization’s role in neurodegeneration and advance therapies to restore neuronal health through precision RNA localization targeting.